Thalamostriatal circuit contributions to behavioral inflexibility following adolescent ethanol exposure

Project Summary
Alcohol use disorder (AUD) is a chronic disease with substantial health and socioeconomic consequences.
Drinking alcohol during adolescence increases the risk of developing symptoms associated with AUD during
adulthood, including heavy drinking. The overarching goal of this project is to identify functional adaptations in
brain circuitry that are caused by adolescent alcohol exposure, and to determine the role of those adaptations
in maladaptive behaviors. Deficits in behavioral flexibility (i.e., impaired ability to alter behavior in response to
changes in the outcome of that behavior) are associated with drug and alcohol misuse. Previous studies show
that alcohol exposure during adolescence decreases behavioral flexibility in adult rodents. This proposal will
explore the impact of adolescent alcohol exposure on brain circuitry involved in behavioral flexibility.
Specifically, the proposed studies will determine the effects of adolescent alcohol exposure on neurons in the
centrolateral nucleus of the thalamus (CL) that project to the dorsomedial striatum (DMS). Lesion or inhibition
of these neurons causes deficits in behavioral flexibility in commonly used tasks including reversal learning and
attentional set-shifting. These deficits are similar to those observed after adolescent alcohol exposure;
however, the impact of alcohol on these neurons, and the involvement of CL neurons in alcohol-induced
deficits in behavioral flexibility, have not been explored. The central hypothesis is that adolescent alcohol
exposure reduces activity in DMS-projecting CL neurons, and that reduced CL neuron activity contributes to
impaired behavioral flexibility in male and female mice. The experiments in Aim 1 will compare the physiology
of CL neurons from adult alcohol-naïve mice and mice that were exposed to vaporized alcohol during
adolescence. Brain slice electrophysiology experiments will measure the intrinsic excitability of DMS-projecting
CL neurons as well as their excitatory and inhibitory synaptic inputs. To extend these findings to intact brain
circuits, activity of DMS-projecting CL neurons from alcohol-naïve mice and mice with a history of adolescent
alcohol exposure will be measured during reversal learning. Calcium dynamics in these neurons will be
monitored via fiber photometry using the genetically-encoded calcium indicator jGCaMP7s. Experiments in Aim
2 will test the hypothesis that increasing activity of DMS-projecting CL neurons using optogenetic stimulation
will improve behavioral flexibility in mice exposed to alcohol during adolescence. Results of these experiments
will provide important information about how adolescent alcohol exposure affects thalamostriatal circuitry in the
developing brain and how alcohol-induced changes in thalamostriatal physiology relate to maladaptive
behaviors that contribute to alcohol misuse in adulthood. Discovery of novel circuitry that is impacted by
adolescent alcohol exposure will inform strategies for manipulating circuit activity to reduce alcohol misuse.

Public health relevance
Project Narrative The goal of this project is to explore the role of connections between two brain regions, the thalamus and the striatum, in behavioral flexibility. Adolescent alcohol drinking can reduce the ability to flexibly change one’s behavior in response to changing circumstances (e.g., problems associated with alcohol use), and this behavioral inflexibility is associated with misuse of alcohol and other drugs later in life. This work will provide important insights about how this brain circuitry changes in response to adolescent alcohol exposure and strategies for developing new treatments to reduce alcohol misuse.